Exploiting Cancer Metabolism and Drug Efflux with Bystander-Assisted Immunotherapy

ABSTRACT. Two hallmarks of drug resistance in cancers are irregular metabolism and drug efflux. In multidrug-
resistant cancers, both of these processes disarm the efficacy of chemotherapeutics, ultimately resulting in de-
creased chemotherapeutic efficacy and increased mortality. Several strategies in development attempt to miti-
gate the effects of drug resistance by modulating specific metabolic pathways or disrupting drug efflux. Specifi-
cally, these strategies include inhibitors, interference RNAs, and nanomedicine approaches. However, a funda-
mental challenge to these strategies is the off-target toxicity that arises from disrupting metabolism or drug efflux
mediated by P-glycoprotein (P-gp), as these mechanisms are also critical to a number of healthy processes
throughout the body. To address this, our long-term objective is to develop a therapeutic strategy that exploits
both of these mechanisms of drug resistance in tandem to generate a therapeutic anti-cancer immune repsonse.
Our central hypothesis is that rationally designed prodrugs can co-opt cancer cell metabolism and drug efflux to
cause an anti-cancer immune response via a mechanism of action we have termed Bystander Assisted Immu-
noTherapy (BAIT). In BAIT, an enzyme-directed prodrug is first metabolized to an immunotherapeutic metabolite
by the irregular metabolism of multidrug-resistant cancer cells. Next, the immunotherapeutic is transported, via
P-gp-mediated drug efflux, to the extracellular space. This results in the activation of bystander immune cells in
local proximity, which initiate an anti-cancer immune response. Because BAIT requires tandem metabolism and
drug efflux, we anticipate a uniquely enhanced specificity for multidrug-resistant phenotypes that exhibit both of
these processes. To develop rationally designed BAIT prodrugs, we first identify small-molecule immunothera-
peutics that are susceptible to drug efflux. In concurrent studies, we also develop synthetic enzyme-directing
groups that modulate the activity of immunotherapeutics and are specifically removed by enzymes expressed in
the irregular metabolism of multidrug-resistant cancer cells. Combining these two research areas, we generate
enzyme-directed BAIT prodrugs that confer immunogenicity to multidrug-resistant cancers. In-vitro, this is con-
firmed in co-cultures of immune cells and cancer cell lines that express these metabolic enzymes and P-gp. In-
vivo, we use a murine model system for prostate cancer (TRAMP-C2 allograft) to demonstrate that BAIT pro-
drugs result in lowered toxicity, decreased tumor volume, and increased progression-free survival, relative to
conventional immunotherapeutics in immunocompetent mice. Taken together, we envision that this research will
establish BAIT as a therapeutic strategy that is enhanced, rather than disarmed, by drug resistance. It is our
long-term vision that this strategy could be widely applicable to multidrug-resistant cancers that evade the action
of conventional therapies through altered metabolisms and drug efflux.

Public health relevance
PROJECT NARRATIVE. The ability of cancers to develop resistance to chemotherapy is a longstanding problem that causes significant mortality. Our research program develops a new class of drug that hijacks the metabolism of drug-resistant cancer cells, causing the body's own immune system to recognize and clear the cancer. We envision that this technique could be developed into a new type of therapy that has both fewer side-effects than conventional chemotherapy and enhanced efficacy relative to established immunotherapies.